Wabanaki NARCH Admin

ADMINISTRATIVE CORE: ABSTRACT
The Wabanaki Native American Research Center for Health (NARCH) will be organized into an Administrative
Core, 1 Research Project and 2 Capacity Building Projects. The Administrative Core will be directed by 2
Principal Investigators: Lisa Sockabasin RN, BSN (Passamaquoddy), Director of Programs and External Affairs
at Wabanaki Public Health and Patrik Johansson, MD, MPH (Cherokee and African American ancestry), an
Associate Professor at the Elson S. Floyd College of Medicine at Washington State University. The
Administrative Core integrate the strengths of both Principal Investigators and their respective organizations. Ms.
Sockabasin is regionally recognized for her expertise, experience, and leadership in public health practice,
including the administration of large-scale public health programs that address tribal priorities and health
disparities. Dr. Johansson is a faculty member at the Institute for Research and Education to Advance
Community Health, a large, well-funded unit at Washington State University devoted to conducting research and
education with underserved communities. He has collaborated with Ms. Sockabasin on research and education
initiatives since 2001 and with Wabanaki Public Health for more than a decade, most notably on 2 large health
assessments. The Administrative Core will be led by Ms. Sockabasin who will be responsible for the overall
planning and coordination of the Wabanaki NARCH, including preparing budgets and annual reports for the
sponsor, as well as personnel appointments, space allocation, and operations at Wabanaki Public Health.
Assisted by Dr. Johansson, she will manage the administrative, fiscal, and management components of NARCH.
Dr. Johansson will oversee NARCH-related activities at Washington State University. Our Specific Aims are to:
1) Support logistical and field operations, including coordination of meetings and travel, and facilitate interactions
between the 2 organizations; 2) Oversee a plan for management, organization, and communication that
stimulates, coordinates, integrates, and monitors activities and functions across and within the RP and the CBPs;
3) Supervise and facilitate implementation of key strategic decisions, research regulatory processes, and data
sharing plans; 4) Collaborate on program planning, review, and evaluation to ensure that the Wabanaki NARCH
achieves its goals and maintains its focus on the Research and Capacity Building Projects; and 5) Convene the
Executive Committee and the Community Elders Action Committee. In summary, the Core will manage,
coordinate, and supervise the entire range of NARCH activities; monitor progress; ensure that component plans
are implemented; and verify that all Wabanaki NARCH-supported research is carried out in compliance with
federal regulations and policies.